DP21-001 Wyoming PRAMS

Project Abstract
PRAMS (Pregnancy Risk Assessment Monitoring System) is a population-based risk factor surveillance
system designed to identify and monitor behaviors and experiences of women before, during, and after
pregnancy. In April of 2006, the Wyoming Department of Health was awarded a grant from the Centers
for Disease Control and Prevention (CDC) to establish PRAMS in Wyoming. Wyoming is focused on
illuminating disparities within the state. The PRAMS project oversamples mothers of low birth weight
infants and American Indian women. These women are oversampled to obtain adequate representation
for analysis. Additional populations of interest include women receiving Medicaid and women enrolled
in the Women, Infants, and Children’s (WIC) program during pregnancy.
PRAMS data is collected by surveying a monthly sample of approximately 100 Wyoming women who
had a live birth in the past two to six months. Wyoming PRAMS uses a combination of two data
collection approaches: statewide mailings of the surveys and telephone follow-up with women who do
not return the survey by mail. The written questionnaires and telephone interviews can both be
completed in Spanish when necessary. Wyoming plans to add a third source of contact via email
beginning in 2021. Email should allow women, who previously had been unable to be contacted via
phone or mail, to be otherwise reached.

Public health relevance
WY PRAMS PROJECT NARRATIVE See document entitled WY PRAMS PROJECT NARRATIVE 2021 in “Other Attachments.”